Using Virtual Reality to help develop discrepancy and elicit change talk in brief motivational interventions for heavy drinking young adults

Project Summary/Abstract
Alcohol use is the leading risk factor for premature death among young adults globally. Brief motivational
interventions (BMIs) can help young adults reduce their drinking. However, recent research has suggested that
these interventions often have modest overall effects. Research exploring novel ways of boosting the effects of
BMIs could help expand their impact. Studies exploring why interventions based on motivational interviewing
(MI) work suggest that a key mechanism may be that they help develop a sense of discrepancy in clients, or a
sense of incongruence between their current drinking and important priorities or goals. MI counselors often
expand that discrepancy by asking open-ended questions that encourage clients to consider the inconsistency
between their current behavior and important values and life priorities. To be successful, however, these
techniques depend on clients’ engagement and investment in the exercise. Virtual Reality (VR) could provide a
method of encouraging more meaningful reflection on discrepancies between drinking and desired goals that
reduces client resistance to change. VR has been used as an adjunct to counseling to help treat a variety of
behavioral, cognitive, and mental health problems with considerable success, but very few such programs exist
to address hazardous drinking, and those that do are only fitting for those who have already decided to
change. Recently, interest has grown in using VR to create transformative experiences that inspire awe,
increase empathy, and encourage positive change. Through collaborations with local VR experts, we designed
an immersive VR experience to help develop discrepancy and elicit change talk in MI sessions that uses an
approach similar to the “looking forward” technique. We then constructed a prototype and tested it with 15
hazardous drinking young adults. At 30-days post-intervention, participants reported 54% fewer heavy drinking
days and 60% fewer alcohol-related problems. Qualitative data also suggested that the immersive nature of
the experience may have accounted for much of its impact. The goal of the proposed research is to design,
build, and pilot test a complete VR experience using user-centered design research methods and the input of
subject matter experts. In Phase 1, we will build the VR experience through an iterative process of up to five
build-test-refine cycles in which progressively more complete versions of the experience are evaluated through
several rounds of testing with intended users (hazardous drinking adults, N=15 each). Findings from these
cycles will be used to refine the experience. In Phase 2, we will test the efficacy of the completed experience in
96
young adult (age 18-34;
target N=82
) hazardous drinkers, who will be
randomly assigned to receive either
(1) BMI with VR, or (2) BMI only.
We will assess feasibility, tolerability, and alcohol outcomes over 6-months
post-intervention. Finally, we will conduct qualitative in-depth interviews with college and community addiction
treatment center directors (N=30) to explore clinic-level barriers and facilitators to implementation of VR.

Public health relevance
Project Narrative This research will support the development of a fully immersive Virtual Reality (VR) experience that can be used in interventions inspired by motivational interviewing to help develop a personal and vivid sense of discrepancy between users’ desired behavior and current levels of drinking. The proposed research will first develop the VR experience through several cycles of user-centered design research with hazardous drinking, young adult users (Phase 1), and then pilot test whether young adults who received a VR-enhanced brief motivational intervention (BMI) drink less and experience fewer alcohol-related problems over six months than those receiving a standard BMI (Phase 2). We will also explore clinic-level barriers to VR implementation among directors of college and community addiction counseling clinics (Phase 3).